Molecular basis of decreased susceptibility to beta-lactam antibiotics in Streptococcus pyogenes

DESCRIPTIVE TITLE: Molecular basis of decreased susceptibility to beta-lactam antibiotics in
Streptococcus pyogenes
PROJECT ABSTRACT/SUMMARY
The human bacterial pathogen Streptococcus pyogenes (group A streptococcus, GAS) causes more than
700 million human infections annually worldwide. Beta-lactam antibiotics are, and have been, the first-line
treatment for GAS pharyngitis and invasive infections. For reasons that remain shrouded in mystery and
speculation, this pathogen has continued to be uniformly susceptible to beta-lactam antibiotics for 70 years.
However, a recent paper described two GAS infection-causing strains with significantly decreased
susceptibility to the beta-lactam antibiotics ampicillin and amoxicillin, causing great concern in the United
States and international infectious disease community. This revelation, coupled with our recent discovery that
invasive GAS strains with significantly decreased susceptibility to beta-lactam antibiotics are far more
common and geographically widespread than previously thought, have served as the catalyst for the
research proposed herein. To achieve our goal of greatly enhancing current understanding of the relationship
between specific gene mutations and decreased GAS beta-lactam susceptibility, the following two specific
aims are proposed. Specific Aim 1: Sequence and analyze the genomes of >11,000 strains to define the
spectrum of mutations present in the penicillin-binding protein 2X (pbp2x) and penicillin-binding protein 1A
(pbp1A) genes in GAS recovered from pharyngitis and asymptomatic carriers. We will determine MICs for nine
commonly used beta-lactams on 2,750 (25%) of the strains. Mutations in these two genes are known to confer
decreased beta-lactam susceptibility in many organisms, including pathogenic streptococci. We will exploit our
unique collection of 40,000 GAS strains recovered over decades from global sources. Specific Aim 2:
Construct and analyze 50 isogenic mutant strains to test the hypothesis that specific naturally-occurring
amino acid replacements in PBP2X and PBP1A decrease the susceptibility of GAS to beta-lactam
antibiotics, as judged by MIC susceptibility analysis. The results of the studies proposed in these two aims
will provide extensive unique data necessary to more fully understand the scope of this critical new
antimicrobial resistance threat. It is reasonable to speculate that the resulting data may also ultimately lead
to novel translational strategies to prevent, limit, and treat antibiotic-resistant GAS infections. A key motivation
is to generate and make available this extensive molecular data in a very short timeframe so that it can be of
the greatest use to the research, medical, and public health communities. We believe much of the proposed
research should have been done two decades ago, soon after it was recognized that we had massive gaps in
our knowledge about how GAS develops decreased susceptibility to beta-lactam antibiotics. Foremost, the
proposed research will generate a community data resource that can be mined and used by all individuals
studying GAS infections and antimicrobial resistance from different areas of emphasis.

Public health relevance
PROJECT NARRATIVE Streptococcus pyogenes is a human-specific pathogen that causes >700 million infections annually worldwide, with treatment of these infections accounting for substantial antibiotic consumption globally. For greater than seven decades, GAS has remained uniformly susceptible to beta-lactam antibiotics; however, strains with significantly decreased susceptibility to this class of antibiotics have recently been identified by ourselves and others. The focused goal of this proposal is to exploit our genomic, bioinformatic, clinical microbiology, and molecular genetics expertise to analyze the molecular basis of decreased GAS susceptibility to beta-lactams and rapidly provide extensive new fundamental information about pathogen genes contributing to decreased antimicrobial susceptibility that may ultimately assist formulation of novel translational strategies to prevent and treat GAS infections.